Administration and Coordination Core

SUMMARY/ABSTRACT
Administration and Coordination Core
Gary Stein, Core Leader; Janet Stein, Co-Leader
The Administration and Coordination Core will provide leadership, and administrative and fiscal support to
facilitate integration of the three projects and the shared resource core (Experimental Integration, Design and
Analysis Core) that comprise the Program Project. The core will coordinate a thematically integrated and
maximally cohesive research program across the two sites—the University of Vermont (UVM) and the Albany
College of Pharmacy and Health Sciences Vermont campus (ACPHS). The Administration and Coordination
Core has the following responsibilities:
Overall Program Project management to promote interactions among investigators
Program planning and evaluation of progress in each research project and the Experimental Integration,
Design, and Analysis Core
Prioritization and integration with the Experimental Integration, Design, and Analysis Core to optimize data
management and coordination, analysis, and public dissemination
Communication and coordination within the program and with external and institutional collaborators
Organization of Internal and External Advisory Committee meetings and seminars
Budget preparation and financial management, including scheduled fiscal reviews and financial reports
Personnel management (recruitment of technical staff, coordination of immigration documentation, health
insurance and benefits)
Manuscript and progress report preparation, correspondence, management and organization
Assistance with ordering reagents and supplies
Scheduling and logistics for frequent Program Project meetings
Travel arrangements for External Advisory Committee members and Program Project researchers
Compliance with institutional, state and federal requirements for health, biosafety, and human-specimen and
animal protocols
Logistics for resource sharing among program investigators and with the broader scientific community

Public health relevance
NARRATIVE Administration and Coordination Core Gary Stein, Core Leader; Janet Stein, Co-Leader The Administration and Coordination Core will provide scientific leadership and management, program coordination and communication, and administrative and fiscal support for the Program to maximize collaborative pursuit of epigenetic mechanisms that impact genome organization and gene expression in the context of biological control and cancer. This Core has an important role in facilitating integration of the three research projects and the shared resource core, as well as with institutional and external collaborators.